Training Program for Innovative Engineering Research in Surgery and Intervention

TRAINING PROGRAM SUMMARY
Over the past several decades, dramatic breakthroughs in biomedical science have been witnessed within
laboratory research. The ability to translate those discoveries as well as to make new discoveries within human
investigations has been a challenge and has been often characterized as the bottleneck of clinical research.
Added to this context has been the dramatic changes to healthcare organizational environments, constraints on
delivery, efficiency, and reimbursements to include major structural changes to the investment in healthcare
research, both federally, and industrially. Lastly, as a result of dramatic systemic changes in healthcare funding
structure, the impact on higher educational graduates’ careers, specifically doctoral graduates, has been quite
profound. Within that changing dynamic landscape, we hypothesize that the fundamental bottlenecks associated
with clinical translational research can be dramatically loosened with the training of engineers intimately familiar
with human treatment and trained in the inception of novel technology-based platforms. We further hypothesize
that continued scientific discoveries within the human environment as well as novel treatment approaches are
highly dependent on these technology-based platforms. The purpose of this training program is to create a new
cadre of researchers capable of creating, developing, implementing, clinically evaluating, and translating
methods, devices, algorithms, and systems designed with a clear focus at one particular application of medicine,
namely, to facilitate surgical/interventional processes and their outcomes. Thematically, our trainees and training
program will have a central focus – innovative platform technologies for treatment and discovery. While this
training program addresses pressing problems in biomedical research, namely the translation and facilitation of
human investigative systems, the program also speaks to improving higher education career trajectories by
providing a novel professional development atmosphere. Briefly described, the training program is a year 2, 3
program that centers on a novel dual-course clinical immersion sequence (a first course that is a context heavy
experience with physicians introducing their specialty and clinical realities, and a second course that is an
intensively immersive environment with students embedded within the clinical team). In both courses, students
are required to engage in expository writing associated with disease and therapeutic analysis, provocative
question solutions, clinical outcome analysis and reviews, and mock grant applications. This framework supports
a unique educational paradigm brought to engineering education. Apart from this sequence, training continues
with addition course work among areas associated with surgical/interventional guidance and delivery,
interventional imaging, medical image processing and analysis, robotics and medical device design, modeling &
simulation, interventional therapeutics, and new to this cycle, interventional and surgical data science. This all
takes place in one of the most strategically collocated environments for engineering, surgery, and intervention
in the world. This is a Training Program for Innovative Engineering Research in Surgery and Intervention.

Public health relevance
NARRATIVE The purpose of this training program is to create a new cadre of researchers capable of creating, implementing, evaluating, and translating methods, devices, algorithms, and systems to facilitate surgery and intervention. Thematically, the program has a central focus – innovative platform technologies for treatment and discovery.